Brain neural networks regulating inflammation

Project Summary/Abstract
Inflammation, the primary biological response to injury and infection, is essential for survival and under precise
neuronal control. Sensory neurons, which densely innervate all bodily tissues, report the occurrence of
inflammation to the brain, because cytokines and other inflammatory mediators stimulate action potentials. The
arrival of incoming sensory signals stimulates brain neurons to send regulatory signals that return to the body
and regulate cytokine production. The vagus nerve, a major conduit for body-brain signaling, inhibits
inflammation and cytokine production in arthritis, colitis, ischemia, organ transplantation, anxiety-depression,
diabetes, and other conditions. In preliminary studies, we (1) used optogenetics and functional mapping to reveal
cholinergic neurons in the brain stem significantly increase splenic nerve activity and inhibit TNF production via
a significantly specific neuronal pathway; (2) assembled a unique bioelectronic vagus nerve recording toolkit and
nociceptor transgenic mouse colonies to reveal sensory vagus nerve pathways activated by IL-1 and TNF; and
(3) adapted Cre-based mouse lines and virus constructs enabling the functional combination of mapping
activated brain networks and subsequent targeted reactivation of these networks using pharmacogenetics. We
identified brain neural networks that respond specifically to IL-1 and TNF, but the function of these networks on
the development and progression of inflammation remain undefined. Our long-term goal is to reveal brain neural
networks regulating the onset and progression of inflammation, particularly within the setting of inflammatory
arthritis in which sensory neuron activation plays a key etiologic role. The objective of this grant is to characterize
the role for brain neural network activity in arthritis onset and progression. The central hypothesis is that brain
neural network activity plays a critical role in regulating inflammatory arthritis, and the activation of these neurons
regulates inflammation. Despite the clinical relevance and the direct importance to understanding basic
functional neurological mechanisms of inflammation, the role of brain networks controlling the onset and
progression of inflammatory arthritis is completely understudied. Our rationale is that identification of the
mechanism(s) to modulate brain neurons in the setting of inflammatory arthritis will reveal new therapeutic
opportunities. Here, we will leverage powerful genetic, pharmacogenetic, optogenetic, and bioelectronic
approaches for functional mapping and neural circuit analysis to unravel how brain networks are activated by
peripheral signals and how they relay outputs to the vagus nerve to impact inflammatory physiological responses.
We Aim to use (1) our recently developed genetic techniques which we have used to “trap” subsets of neurons
during conditions of activity induced by exposure to cytokines to define brain neural network activity during the
onset and progression of inflammatory arthritis and (2) our recently developed pharmacogenetic techniques to
selectively “reactivate” these same brain network neurons to assess the mechanisms by which these networks
modulate vagus nerve signaling, and therefore, the onset and progression of inflammatory arthritis. The
proposed research is innovative because we investigate the effect of brain neural network activity on
inflammatory arthritis, a previously unstudied mechanism.
1

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding how the brain processes incoming inflammatory signals during inflammation and arthritis and the degree to which it regulates the onset and progression of tissue damage is expected to guide the development of new types of treatments and diagnostics for inflammation by specifically targeting functional brain networks. Thus, the proposed work is pursuant to the NIH’s mission fostering basic, novel and creative discoveries and innovative research strategies in order to ultimately enhance health. 1